Astrocyte Calcium Signaling in Chronic Pain.

SUMMARY
Acute nerve injuries often lead to chronic pain. Chronic pain is a common condition that can have devastating
impacts on quality of life and there are currently few non-addictive drugs available that effectively treat chronic
pain. Better understanding of how acute injury results in chronic pain is essential to the development of new
pain medications. Chronic pain involves central sensitization, whereby pain networks in the central nervous
system become hypersensitized. During central sensitization astrocytes can be activated by excitatory
neurotransmitters, and activated astrocytes then release cytokines and other factors that are required for pain
network sensitization. These astrocyte functions are regulated by complex Ca2+ signaling mechanisms. The
long-term goals of our research are to define the specific Ca2+ signaling mechanisms required in astrocytes for
chronic pain, because defining these mechanisms may reveal new therapeutic targets for pain intervention. We
address this using powerful genetic tools in a Drosophila model of chronic pain. Our recent work demonstrates
that highly conserved store-operated calcium entry (SOCE) channels are required in astrocytes for the
transition from nerve injury to chronic pain. SOCE channels are activated when endoplasmic reticulum (ER)
Ca2+ stores are depleted and they are an essential component of many Gq-coupled neurotransmitter receptor
signaling mechanisms. SOCE channels are notable for their ability to specifically activate cytokine and other
gene expression through activation of the calcineurin/NFAT signaling pathway. Thus, SOCE channels may
form a vital link between nerve injury-induced astrocyte activation and astrocyte release of neuroactive
cytokines. The specific goals of this proposal are to determine how nerve injury results in the activation of
astrocyte SOCE and to determine the role of SOCE in activating calcineurin/NFAT – mediated
neuroinflammatory signaling required for chronic pain. We will address this by 1) assessing astrocyte
Gq-coupled receptor signaling in injury-induced SOCE activation; 2) testing the ability of SOCE to drive
astrocyte cytokine expression through calcineurin/NFAT activation; and 3) defining the role of gap junctions in
inter-astrocyte propagation of injury-induced Ca2+ signals. The results of this work will bring clearer
understanding of the astrocyte Ca2+ signaling mechanisms involved in pain chronification and may lead to the
development of desperately needed non-opioid pain therapeutics.

Public health relevance
NARRATIVE Acute nerve injuries often transition into chronic pain, a devastating condition for which there are few effective treatments. Astrocyte calcium signaling is an essential component of the central nervous system changes that underlie the transition to chronic pain. This proposal will test the role of specific astrocyte calcium signaling mechanisms in pain chronification with the long-term goal of identifying new therapeutic targets.